FOOD EFFECT ON BIOAVAILABILITY OF FLT IN ASYMPTOMATIC HIV POSITIVE PATIENTS

In this (FLT) study, patients are given twice daily oral doses of (FLT) with meals to determine if the oral bioavailability and pharmacokinetics of (FLT) are altered in the fed state.